Shared Resource Management

PROJECT SUMMARY: SHARED RESOURCE MANAGEMENT
Sylvester Comprehensive Cancer Center (Sylvester) Shared Resources Management (SRM) provides critical
oversight of all the Sylvester Shared Resources (SRs), ensuring ready access to cost-effective, state-of-the-art
research instruments and services. SRM aims to 1) establish, evaluate, maintain, improve, and expand the
SRs; 2) ensure the SRs provide high-quality services and promote research rigor and reproducibility; 3)
facilitate implementation of innovative new SR services; and 4) support the education and training of Sylvester
members, trainees, and staff. With highly qualified leaders and staff, SRM ensures that the SRs are efficiently
operated, effectively advance collaborative and translational research, and successfully implement new
technologies and services. SRM enables the SRs to offer coordinated support for transdisciplinary research by
leveraging the high level of expertise, advanced technologies, and comprehensive array of SR services for
Onco-Genomics (OGSR), Flow Cytometry (FCSR), Biostatistics and Bioinformatics (BBSR), Cancer Modeling
(CMSR), Biospecimen (BSSR), and Behavioral and Community-Based Research (BCSR). SRM supports the
SRs in providing seminars, workshops, and training to optimize the use of SRs by members, trainees, and
staff. SRM performs a continuous review process that evaluates usage, operations, finances, and impact of the
SRs, and enables member feedback to ensure that SR capabilities align with Sylvester's Strategic Plan and
with member and catchment area needs. During the current reporting period (6/1/2018-5/31/2023), Sylvester
recruited George Grills as Associate Director Shared Resources, to provide expert oversight of the SRs and to
oversee SR improvement and growth, with input from SR Faculty Advisory Committees and Sylvester's
Scientific Steering Committee. SRM supported the growth of two developing SRs (CMSR and BSSR);
facilitated the implementation of 19 major instruments across three SRs (OGSR, FCSR, and CMSR); and
managed expansion in SR staffing (from 54 to 7 4 personnel) that was needed to match the increase in the
scale and scope of SR services. SRM supported the SRs in providing services to 83% (123 members) of the
current 148 members. Members comprised 84% of SR usage as measured by revenue, reflecting the critical
importance of the SRs to members' research. Each SR was used by all Research Programs. SRM facilitated
the SRs' support of 334 cancer-related publications by members, with 29% (98 publications) in high-Impact
journals (JIF ~10); 227 cancer-related grant awards to members, including 31 NCI awards; and 108 cancer-related
clinical research studies (75 by members). Aligned with the 2024-2028 Sylvester Strategic Plan's goals,
SRM future plans are to 1) implement emerging technologies and innovative services in existing SRs; 2)
establish new developing SRs and capabilities; 3) expand integrated multi-SR services; 4) enhance SR
support of population science and translational research; and 5) expand SR support for data management and
analysis of large-scale datasets to further meet the needs of the catchment area.